Mechanisms of clonal competition in age related clonal hematopoiesis

Project Summary/Abstract
With age, hematopoietic stem cells (HSCs) accrue mutations, some of which provide a competitive
advantage and lead to the expansion of clones bearing the mutations, a phenomenon called clonal
hematopoiesis (CH). CH is associated with inflammation, susceptibility to infections, high risk of cardiovascular
disease, and development of myeloproliferative disorders and cancer. Together, these conditions represent the
leading causes of death in older adults. Recent studies indicate that ~95% of healthy middle-aged adults bear
CH-associated mutations. Although adults with these mutations are at much higher risk of hematologic disorders,
progression from CH to disease states still only occurs in a small subset of these individuals. Many genes are
associated with CH, but mutations in DMNT3a represent a majority of CH-associated mutations. We have shown
that, within DNMT3a mutant HSCs, expansion is driven by a small set of “super-competitor” clones. Given that
higher variant allele frequencies (VAF) of DNMT3a mutations indicate higher risk for hematologic disease,
identifying factors which drive expansion in these clones is of high clinical relevance. We conducted a CRISPR-
based ex vivo expansion screen of genes that are upregulated in DNMT3a mutant cells. Results of the screen
highlighted the gene SLC3a2, whose knockout inhibits rapid expansion and induces synthetic lethality in
DNMT3a mutant cells ex vivo and in transplantation settings. This proposal seeks to investigate the mechanisms
of clonal competition in CH via a three-pronged approach. To validate SLC3a2’s effects in vivo, we will assay the
expansion of DNMT3a mutant, SLC3a2 knockout HSCs and their gene expression profiles in unperturbed
hematopoiesis. SLC3a2 is a component of the CD98 complex, which has dual roles in amino acid transport and
integrin-mediated adhesion. To dissect the functional mechanism of SLC3a2’s effects in clonal competition, we
will conduct pharmacological and genetic disruptions to components of the complex required solely for amino
acid transport, and perform metabolic assays aimed at either phenocopying or rescuing the effect of SLC3a2
KO. Lastly, we will assess SLC3a2’s role in human clonal hematopoiesis using human cord blood CD34+ cells
genetically altered to model DNMT3a-mediated clonal hematopoiesis.
As a postdoctoral fellow, Dr. Quach will conduct his research in the laboratory of Dr. Fernando Camargo
at Boston Children’s Hospital. Dr. Quach will build on his solid background in hematology and translational
research, developing new skills in single-cell transcriptomics and stem cell biology to generate insights into the
mechanisms of clonal hematopoiesis. His mentor, Dr. Camargo, is an expert in hematopoiesis and has
developed innovative technologies for cellular barcoding and clonal analysis. Dr. Camargo’s mentorship and
expertise, a strong scientific advisory committee, and a rigorous research and training plan provide all the
necessary elements for success in the proposed project and Dr. Quach’s transition to independence.

Public health relevance
Age-related defects in the blood underlie many significant health conditions in older adults including higher risk of infections, cardiovascular disease, and myeloproliferative disorders like leukemia. Our lab has recently discovered a set of factors which appear to govern the development of these disorders. This study may uncover mechanisms by which the cells that produce blood deteriorate and may lead to the development of screening and treatment strategies for immune and cardiovascular defects, and blood cancers in older adults.